Dynamical signaling and gene regulation in stress and aging

Project Summary
Cells respond to intracellular and extracellular challenges through intricate signaling pathways. An increasing
number of studies revealed that the temporal dynamics of signaling pathways play crucial roles in controlling
cellular processes. However, the basic mechanisms underlying the regulation and function of signaling
dynamics remain largely unclear. Protein kinase A (PKA) is a highly conserved prototypic kinase that regulates
many cellular behaviors, such as cell growth and stress resistance, through gene expression programs. Under
physiological conditions, PKA displays various temporal dynamics of signaling activity. Defects in dynamic
regulation of PKA activity can lead to disastrous diseases, such as neurodegeneration, cancer and heart
disease. For over a decade, the research in our lab has been focused on understanding the regulation and
function of PKA signaling dynamics upon stress. In this renewal, we propose to expand our research to study
the mechanisms underlying dynamical regulation of PKA signaling in cellular aging and deterioration using
budding yeast as a model system. Our preliminary results showed that PKA activity decreased in a fraction of
aging cells and the interactions between PKA and the heme-activated protein (HAP) complex may drive this
divergence of signaling dynamics among aging cells. Building upon these results, we will combine
computational modeling with quantitative experiments to interrogate the regulatory circuit that drives the age-
induced dynamic changes in PKA signaling. Specifically, in Aim 1, we will perturb the PKA-HAP circuit and
evaluate the effects on PKA dynamics and their roles in regulating aging and lifespan. In Aim 2, we will
evaluate the contributions of PKA dynamics to gene expression changes during aging. In Aim 3, we will
investigate how PKA controls messenger ribonucleoprotein granules, e.g. processing bodies (P-bodies), to
influence the posttranscriptional regulation of gene expression in aging. The completion of this project will
further our basic understanding about the general mechanisms of PKA signaling in aging from a network
perspective and will illuminate molecular causes of age-related diseases, setting the stage for new therapeutic
strategies against them.

Public health relevance
Project Narrative Dysregulation of protein kinase A (PKA) signaling leads to severe age-related human diseases, such as neurodegeneration, heart disease and cancer. This project aims at furthering our mechanistic understanding about the dynamical regulation and function of PKA signaling in aging, laying foundations for therapeutic strategies for mitigating age-related diseases.